Life-space, isolation, and functional exposome study in preclinical Alzheimer's disease and cognitive environments (LIFESPACE)

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) is a global public health priority as nearly 55 million of the world’s population
live with dementia, with cases projected to triple to 150 million by 2050. Dementia prevalence varies across
populations, and differences are due to complex relationships across demographic and social determinants of
health (SDOH). Social isolation may lead to decreased cognitive stimulation, more stress and depression,
higher physical inactivity, and increased neuroinflammation among older adults (OA).
The overarching goal of this study is to examine and improve the validity and the generalizability of
digital signals collected from everyday life, ranging from driving to other activities of daily living, in identifying
biological AD using a large, diverse cohort. Our Specific Aims will (1) Determine the ability of digital markers of
social isolation (smartwatch) and life space (datalogger) to cross-sectionally distinguish between OA
with/without preclinical AD and cognitive impairment, (2) Model longitudinal trajectories as a function of driving
behavior and physical activity to determine if OA with preclinical AD experiences greater life space constriction
and social isolation over time, (3) Explore the effects of S/SDOH factors, including air pollution (PM2.5),
neighborhood deprivation, green space, and cognitive stimulation on social isolation and life space.
To accomplish this, a multidisciplinary team of experts will jointly assemble cohorts representing two
geographically distinct and socio-cultural diverse sites (St. Louis, Greenville). We will capitalize on existing
institutional infrastructure to longitudinally follow 350 cognitively normal older adults in St. Louis and 150
cognitively normal older adults in Greenville. This study will prospectively collect cross-sectional data on
molecular plasma biomarkers, SDOH, and longitudinal digital markers, including naturalistic driving and
physical activity/mobility for three to five years. This proposal is one of the first to examine preclinical AD, the
natural environment, and longitudinal data on life space and social mobility.
Once obtained, this knowledge can be used to map digital signals from daily life as a neurobehavioral
biomarker that may be monitored and used for clinical trials and interventions throughout the disease
progression of AD.

Public health relevance
PROJECT NARRATIVE This research project studies digital signals and data collected from everyday life, ranging from driving and community mobility, to create a digital fingerprint that may flag early changes in social networks and life space within older adults at risk of Alzheimer's disease (AD). We will recruit a geographically variegated sample across rural, suburban, and urban settings across St. Louis, MO, and Greenville, NC, to test the ability of digital markers, including driving behavior, cognition, and physical activity, to predict those at-risk for AD based on blood-based biomarkers. This study is one of the first to examine longitudinal digital data of social isolation and life space constriction as a product of the greater environment, as well as preclinical AD plasma biomarkers.